Streamlined cloning of auditory and vestibular mutants by whole genome sequencing

DESCRIPTION (provided by applicant): Over the last two decades zebrafish has emerged as one of the preeminent model organisms. This rise was in large part due to the promise of using forward genetic screens in a vertebrate animal to discover and elucidate the function of genes relevant to human development and health. Numerous genetic screens have now been performed both for general embryonic morpohological phenotypes as well as more specialized functional screens such as for balance and hearing. These screens have been very successful in identifying mutants and there are now over 6000 described chemically induced mutant lines in zebrafish. However, the gene mutated in these lines has only been identified in less than half the cases due to the current difficulty of positional cloning. The high cost and labor currently required for positional cloning prevents a molecular analysis of many current mutants as well as discouraging future genetic screens. Recent advances in next generation sequencing have reduced the cost of sequencing by several orders of magnitude such that it is now possible to routinely resequence entire genomes. These advances have already revolutionized many areas of genomics yet the way people do positional cloning in zebrafish and other model organisms has changed relatively little. Here we propose to apply next generation sequencing technologies to streamline positional cloning of mutants in model organisms focusing on zebrafish inner ear mutants. Our goal is to reduce the labor and cost of positional cloning by one to two orders of magnitude. We will compare two different approaches for cloning-by-sequencing based on linkage and homozygosity mapping by cloning 10 existing mutants in two mutant classes-semicircular canal morphogenesis and deafness. PUBLIC HEALTH RELEVANCE: Defects in hearing and balance represent a major health problem in humans. Models for these defects can be identified in genetic screens in zebrafish but are currently difficult to molecularly characterize. We will develop an approach to streamline the cloning of such mutants using next generation sequencing.

Public health relevance
Defects in hearing and balance represent a major health problem in humans. Models for these defects can be identified in genetic screens in zebrafish but are currently difficult to molecularly characterize. We will develop an approach to streamline the cloning of such mutants using next generation sequencing.